Imaging intracerebral and systemic T cell immunity in patients with Alzheimer's disease using 18F-F-AraG

Project Summary (Abstract)
Alzheimer disease (AD) is the most prevalent neurodegenerative disorder, with limited treatment
options and no curative interventions. While neuroinflammation driven by innate immune cells is
a well-established hallmark of AD, the role of adaptive immune responses in the disease remains
poorly understood. Accumulating evidence indicates that both intracerebral and peripheral T cells
significantly influence the pathophysiology of neurodegeneration in AD, highlighting the need for
better understanding of both local and systemic immune processes, particularly in the context of
developing successful immunotherapeutic approaches. However, current methods for studying T
cell involvement in AD are inadequate for capturing the complex and dynamic nature of immune-
neuronal interactions in living patients. The inability of currently used methods to detect local and
systemic T cell involvement in living patients with AD represents a major obstacle in our
understanding of the role of the adaptive immune responses in AD and development of successful
immunotherapy approaches. Positron emission tomography (PET) imaging with T cell-specific
agents offers a promising, highly specific, and noninvasive tool for detecting T cell involvement in
AD. We propose to investigate [18F]F-AraG, a small molecule PET agent uniquely well-
suited for imaging systemic T cell activity, as a biomarker for detecting and quantifying T
cell immunity in patients with Alzheimer disease. The immediate goal of this project is the
characterization and validation of [18F]F-AraG as an imaging marker of intracerebral and systemic
T cell activity in patients with AD. Our long-term goal is to develop highly sensitive and specific
noninvasive technique to assess the adaptive immune response and guide development of
immunotherapy interventions in patients with AD. The proposed research will deliver a unique
and clinic-ready imaging approach to address the critical challenge of detecting
intracerebral and peripheral T cell activity in patients living with AD. If proven successful in
imaging aberrant T cell activity in patients with AD, [18F]F-AraG PET could revolutionize treatment
of Alzheimer’s disease by facilitating the development of novel immunotherapy-based strategies
for treating or managing the disease.

Public health relevance
Project Narrative (Relevance) The development of an imaging method for noninvasive detection of aberrant T cell activity in patients with Alzheimer disease is crucial for enhancing our understating of the role of adaptive immunity in the development and progression of Alzheimer disease. This technique has the potential to pave the way for new immunotherapy approaches and fundamentally change the paradigm by which Alzheimer's disease is treated and managed.